Administrative Core

SUMMARY
Invasive fungal infections pose a formidable global challenge, particularly for immunocompromised individuals,
exacerbated by the emergence of drug-resistant strains like Candida auris, Candida glabrata, and Aspergillus
fumigatus. To tackle this issue, we propose establishing a Center of Excellence for Translational Research
(CETR) dedicated to expediting the discovery and development of novel antifungals and a diagnostic. The
establishment of an effective CETR involves developing efficient administrative structures, robust leadership
plans, support infrastructure, and a pharma-style decision-making approach. We will create an integrated
network of science discovery support Cores, including Pharmacology/Mycology, Animal Model, and Medicinal
Chemistry Cores, staffed by experienced directors with BioPharma experience to accelerate lead compound
optimization. The Administrative Core will play a crucial role in optimizing research operations and resource
allocation through a lean framework that closely integrates Project Leaders and Core Directors. This centralized
organization will facilitate seamless communication across multiple entities and manage all operational aspects
of the Projects and Cores, ensuring efficiency and cohesion. We will provide a comprehensive support system
for grant management and commercialization efforts. This includes solutions for secure data sharing and
intellectual property protection, administrative systems for reporting and fiscal management, and communication
protocols for collaboration and dissemination of secure and public data, as well as project reviews and updates.
We will also provide support for product development, and regulatory compliance, ensuring successful initiatives.
The administrative structure ensures maximal efficiency in project execution by streamlining operations and
resource allocation. A robust plan led by experienced drug development experts and a world-class Scientific
Advisory Board (SAB) helps guide drug candidate development and evaluate progression metrics. Pharma-
style decision making with clear 'go, no-go' criteria will be used to expedite and prioritize promising candidates.
External regulatory support aids in navigating requirements for pre-IND, IND-enabling and 510(k) submissions.
These efforts strengthen the administrative core of the CETR-based accelerator. By leveraging the expertise of
academic and industry partners and establishing a robust administrative infrastructure, we aim to combat drug-
resistant fungal pathogens. This comprehensive administrative approach embodies our commitment to
advancing research and translating discoveries into impactful solutions for patients.